Washington University Physician Neuroscientist Training Pipeline (PNTP) Pathway

Abstract
Young investigators are essential to the maintenance of a vibrant Neurology/Neurosurgery physician-scientist
workforce, but are facing increasing clinical demands, diminishing research time, and limited funding for scientific
training. Moreover, the rapid pace of basic neuroscience advancement and the emergence of new enabling
technologies add to the challenges facing these future physician-neuroscientists. To meet this pressing need,
we have built upon the successes of our prior Neurology/Neurosurgery R25 program to establish a
comprehensive UE5 training program that begins during early residency training that aims to recruit and prepare
the next generation of Neurology/Neurosurgery physician-neuroscientists to successfully compete for the best
junior faculty positions in the country, secure extramural career development funding, including K-series grants
from the National Institutes of Health, and ultimately become independent principal investigators. The structure
of the Washington University Physician Neuroscientist Training Pipeline (PNTP) pathway improves upon our
prior R25 program in several fundamental ways: (1) we established a more formalized pipeline beginning early
in residency training to guide and nurture future physician-neuroscientists in neurosurgery and neurology, (2) we
created a resident-led workshop series for Neurology and Neurosurgery trainees that exposes them to faculty
research, career-relevant topics relevant to the transition to independence, and cross-disciplinary research
centers and core facilities at Washington University, (3) we established an annual symposium, pairing R25/UE5
fellow research presentations with an invited distinguished physician-neuroscientist keynote lecture, (4) we
established two advisory groups, an external advisory committee and an operations guidance team, to provide
programmatic oversight and input, and (5) we expanded our training program to now accept neuroscience
research-focused residents from other departments. The Departments of Neurosurgery and Neurology at
Washington University each provide excellent institutional environments for basic, translational, and clinical
neuroscience research and education, with long and distinguished track records of training academic physician-
neuroscientists spanning many decades. In the past decade, over 60% of Neurosurgery graduates have entered
academic practice and nearly 20% of graduates have become successful NIH-funded neurosurgeon-scientists,
while ~80% of Neurology graduates have taken positions at academic medical centers, and 23% have received
independent fellowship grants, K awards, and/or R01 grants to date. Taken together, the proposed PNTP provide
an enhanced and distinct research training pipeline, specifically for neurosurgeons and neurologists, but also
other cognate subspecialists, interested in academic careers as independent neuroscience researchers, with
the overall long-term goal of ensuring that highly-trained physician-scientists will be available to make future
advances to reduce the burden of neurological disease across the lifespan.

Public health relevance
Narrative The Washington University PNTP was specifically designed to meet the growing demand for well-trained neurosurgeon and neurologist physician-scientists conducting basic, clinical, and translational neuroscience research necessary to improve the treatment of patients with neurological disorders across the lifespan. These individuals occupy a unique position in our disciplines, working at the interface between clinical medicine and scientific discovery. The immediate goal of the proposed PNTP is to train neurosurgery and neurology residents in either basic or clinical science research, with the goal of fostering their academic success and development into independent physician-scientists who can further our understanding of the mechanisms, etiology, and treatment of neurological diseases.